Impact of Clonal Hematopoiesis on Solid Tumor Development and Response to Therapy

PROJECT SUMMARY/ABSTRACT
Individuals with clonal hematopoiesis (CH) are at a significantly higher risk to develop solid tumors compared to
age-matched non-CH carriers irrespective of prior therapy. While shared risk factors may contribute, the unique
functions that CH- mutant hematopoietic cells play in solid tumor development remain unknown. Notably, CH
carriers with mutations in the epigenetic regulator TET2 have a strong predilection for development of solid
tumors such as lung cancer, underscoring a critical underexplored area of research with the potential to improve
disease surveillance and treatment strategies. I hypothesize that Tet2-mutant hematopoietic cells play a
critical role in tumor development by conditioning a favorable solid tumor environment into a conducive
landscape for CH-mutant cell growth and proliferation. Aim 1 of this proposal will quantify the impact of Tet2-
mutant hematopoietic cells on lung-specific tumor development and response to radiation therapy (RT) as Tet2
mutations are frequently found in solid tumors and lung cancer is among the most frequent solid cancer type to
arise in a CH background. Building on preliminary data which displayed enhanced tumor growth in a Tet2-mutant
background, I will create chimeric mice with a Tet2-mutant hematopoietic system followed with establishment of
solid lung-specific tumors. After determining normal tumor growth and metastatic patterns, targeted RT will be
utilized to capture tumor volumetric response to therapy. Aim 2 will identify the spectrum of CH-mutant immune
cells that infiltrate the tumor and define the role(s) they play in the tumor microenvironment (TME). Pilot
experiments revealed overrepresented tumor infiltration of Tet2-mutant monocytes. I will investigate these target
cell populations by conditional activation and deletion in genetic mouse models to address if specific, mutant cell
populations enhance tumor development. In parallel, tumor infiltrating monocytes will be evaluated for aberrant
transcriptional statuses and could provide attractive targets to mitigate solid tumor growth/resistance to therapy.
Aim 3 will evaluate the cytokine profiles within solid tumors and how this environment uniquely shifts in the
presence of Tet2-mutant hematopoietic cells. Pilot studies reproduced known aberrant cytokine levels induced
by TET2 CH in humans, with TNFα emerging as a highly upregulated cytokine which further proved amenable
to pharmacological reduction in preliminary experiments. The primary focus will be on the impact of TNFα
neutralization on tumor burden, while a comprehensive cytokine profiling will ensure no potential therapeutic
targets are overlooked. This project will address a knowledge gap that affects a large patient population who
develop solid tumors with a background of CH mutations. The results of this research proposal will identify new
insights into the function of CH-mutant cells and how they drive solid tumor development which could unveil
pivotal mechanisms offering new avenues for targeted therapies and intervention strategies.

Public health relevance
PROJECT NARRATIVE This project aims to identify the role(s) of mutant hematopoietic cells, often associated with clonal hematopoiesis (CH), in solid tumors. As hematopoietic involvement is a main driver of tumor formation, development, and therapy response, solid tumors which arise in the background of a hematopoietic landscape harboring CH- associated mutations could have a variety of unique consequences. Identifying the fate and function of these CH-associated mutant cells in solid tumors could provide insights towards how to improve disease surveillance, treatment options, and ultimately patient outcomes.